Elucidating the functional role and therapeutic potential of GPCR kinase 2 in primary and therapy-resistant basal cell carcinoma

Inappropriate activation of the Hedgehog (HH) pathway drives basal cell carcinoma (BCC) of the skin, the most
common cancer in the United States with greater than 4 million cases annually. Existing drugs target oncogenic
HH signaling by inhibiting the key pathway regulator SMOOTHENED (SMO). Tumors initially respond to SMO
inhibitors, but these molecules ultimately lose effectiveness, largely due to secondary mutations within SMO that
render it drug-resistant. To elicit expression of oncogenic target genes involved in tumorigenesis, SMO signals
intracellularly to GLI transcription factors, but for decades the underlying signaling mechanism remained
obscure. We recently identified a key aspect of SMO-GLI communication that enables us to propose new
therapeutic strategies to minimize resistance issues. Working in cultured cells and embryos, we discovered that
the active, agonist-bound form of SMO undergoes phosphorylation by the kinase GRK2, enabling SMO to directly
bind the PKA catalytic subunit, inhibit its enzymatic activity, and thereby prevent PKA from phosphorylating and
inactivating GLI. We hypothesize that this novel SMO-GRK2-PKA signaling pathway transmits oncogenic HH
signals from the cell surface to the nucleus during BCC tumorigenesis. As such, GRK2 represents a promising
therapeutic target for both primary and SMO inhibitor-resistant BCC. The goal of our MPI R01 grant is to define
the role of GRK2 in mediating oncogenic SMO-GLI communication in BCC, elucidate the underlying mechanism
of phosphorylation, and to evaluate GRK2 inhibition as a BCC therapeutic strategy. Using cultured cell and in
vivo BCC models, we will determine whether SMO undergoes GRK2 phosphorylation in primary cilia and probe
the functional significance of these phosphorylation events to oncogenic GLI activation and BCC tumorigenesis.
We will also block GRK2 activity using either genetic or pharmacological approaches, the latter capitalizing on
selective, high-affinity, bioavailable GRK2 inhibitors that have already been developed and utilized in
cardiovascular disease models. Lastly, we will uncover the biochemical and cell biological mechanism by which
GRK2 recognizes the SMO active conformation at the cell membrane, which is its essential role in HH signal
transduction, and capture a cryoEM structure of SMO-GRK2 or SMO-GRK2-Gβγ complex to understand this
process at atomic resolution. To carry out our studies, we have assembled a team of experts in biochemical /
cell biological mechanisms of HH signal transduction (Myers), BCC tumorigenesis (Atwood), and GRK2 structure
/ pharmacology (Tesmer). We expect these studies to define an essential and unique role for GRK2
phosphorylation of SMO in transmitting oncogenic HH signals from the cell surface to the nucleus, and for GRK2
inhibition, either alone or as a combination therapy with FDA-approved SMO inhibitors, to block tumorigenesis
and forestall resistance more effectively than existing standard methods of care. Overall, our work will provide
valuable insights into the mechanism of BCC tumorigenesis and validate a novel BCC therapeutic strategy, with
the potential to transform treatment paradigms for many malignancies driven by ectopic SMO or GRK2 activity.

Public health relevance
Basal cell carcinoma of the skin, the most common cancer in the United States, can arise when a key cancer- promoting cellular signaling pathway called Hedgehog is switched on within normal cells. The goal of the proposed research is to study the role of GRK2, a key protein in the Hedgehog pathway, to establish its role in basal cell carcinoma and evaluate its utility as a therapeutic target in this cancer. Our research is relevant to the mission of NCI because it will increase our understanding of how basal cell carcinoma develops and lay the groundwork for a new, more effective and more durable targeted chemotherapy that will increase the quality of cancer patients’ lives.